Pronociceptive and antinociceptive opioid mechanisms in the central nucleus of the amygdala

Project Summary
Multiple lines of evidence support wide-spread structural and functional maladaptations in brain circuits as a
contributing factor promoting chronic pain. Dysregulation of descending pain modulatory circuits have been
demonstrated in chronic pain patients. However, our understanding of the molecular mechanisms and brain
circuits that underlie inhibition or facilitation of pain under normal and pathological conditions remains limited.
Opioid analgesics engage these brain circuits, but non-addictive options to treat pain are urgently needed.
In this proposal, we will investigate pain modulatory mechanisms in the amygdala, a structure involved in
integration of pain-related sensory inputs and emotional processing. We will test the hypothesis that functionally
opposing endogenous mu (MOR) and kappa (KOR) opioid circuits in the central nucleus of the amygdala (CeA)
inhibit or promote, respectively, pain behavior. Bidirectional descending pain modulatory circuits have been
characterized most extensively in the rostral ventromedial medulla (RVM). However, little is known about
descending modulatory circuits above the brainstem. In the RVM, pro-nociceptive and anti-nociceptive functions
are mediated by MOR-expressing “pain ON” cells and KOR-expressing “pain OFF” cells. We propose that similar
functional organization with MOR- and KOR-expressing cells serving opponent roles in sensory and/or affective
pain behavior also exists in the CeA. Importantly, the reciprocal function of the MOR and KOR circuits may
represent a general organizational principle for pain modulation in other brain areas.
We will use transgenic mouse models in combination with optogenetic and chemogenetic approaches and
anterograde and retrograde tracing for the cell type-specific and projection-specific analysis of MOR and KOR
circuits in the CeA and their contribution to pain behaviors in a neuropathic pain model (spinal nerve ligation).
Specific Aim 1 will determine the anatomical characteristics of KOR and MOR cells in the CeA. Specific Aim 2
will explore the synaptic and cellular effects of KOR and MOR activation or inhibition and their interaction.
Specific Aim 3 will assess the role of MOR and KOR circuits in pain behaviors using reflexive responses
(mechanical and thermal thresholds) as well as complex behaviors related to affective and motivational qualities
of pain (vocalization, conditioned place preference/avoidance). Eletrophysiological and behavioral outcomes will
be assessed with cell specific manipulations under control conditions and in a neuropathic pain model in both
male and female mice allowing the determination of possible sex differences in the amygdala circuit.
The proposed studies will identify a previously unknown KOR-mediated pro-nociceptive amygdala circuit and its
relationship to MOR-mediated anti-nociceptive mechanisms. Impaired MOR signaling and/or increased KOR
signaling in the CeA may result in an inhibition-excitation imbalance of descending modulation to promote chronic
pain. Importantly, the opposing MOR-KOR function in the CeA would provide the conceptual basis for the
development of non-addictive therapies for chronic pain.

Public health relevance
PROJECT NARRATIVE The amygdala is an important brain structure integrating sensory and emotional qualities of pain. This project will identify and characterize opposing opioid circuits in the central nucleus of the amygdala involving kappa and mu opioid receptor-expressing neurons that respectively promote and inhibit pain behaviors. Understanding of the amygdala pro-nociceptive and anti-nociceptive mechanisms will allow development of novel therapeutic strategies for the treatment of chronic pain.